BASIC RESEARCH--CANCER INSTITUTE FREDERICK

Their is a contrast for the support of the Frederick Cancer Facility. Basic Research Program in the areas of : Mammalian Genetics Eukaryotic Gene Expression Genetics and Recombinant DNA Molecular Mechanisms of Carcinogenesis Molecular Virology and Carcinogenesis Chemical and Physical Carcinogenesis Crystallographic analyses